Neuroregeneration after stroke using Vascular Guidance

Project summary
This study addresses the challenge of improving neural progenitor (NP) survival and migration in the context of
neurodegenerative diseases and brain injuries. It investigates the potential of adult CNS endothelial cells (ECs) to express
developmental genes following epigenetic reprogramming, aiming to guide NP migration and enhance neurovascular
communication. The research also delves into the capacity of CNS vessels, induced with developmental gene cohorts, to
boost NP survival and migration in stroke-affected brains. Specific aims include comprehensive migration assays and the
evaluation of post-stroke brain recovery through detailed assessments of NP survival, migration, and differentiation. The
anticipated outcomes seek to contribute fundamental knowledge and potentially transform neural progenitor treatment
strategies, proposing a novel approach that combines vascular rejuvenation with NP transplantation for improved
cognitive and motor skills and overall enhanced clinical outcomes. If successful, the results of this application will
significantly influence the design of neural progenitor (NP) transplant-treatment strategies for neurological disorders,
including stroke.

Public health relevance
Project Narrative Neuronal loss in neurodegenerative diseases and brain injuries necessitates innovative treatments. While transplanting neural progenitor cells (NPCs) offers therapeutic promise, their limited survival and migration hinder efficacy. To overcome this challenge, we aim to epigenetically reprogram CNS vessels, enabling them to provide survival factors and guidance cues for transplanted NPCs, facilitating the reconstruction of lost circuit connections.